NMR Studies of Structures and Dynamics of Proteins

DESCRIPTION (provided by applicant): Conformational changes of proteins are required for nearly all proper biological functions and inappropriate conformational changes are associated with numerous pathologies. In particular, processing of DNA and RNA molecules by proteins is fundamental to human health, including cell division and homeostasis, and disease, including cancer and viral infection. Comprehensive experimental information on the essential contributions of intramolecular dynamics to biological functions of proteins is critical for biophysical theories of equilibrium properties, such as heat capacity and thermal stability; for mechanistic interpretations of kinetic processes, such as enzyme catalysis and ligand recognition; and for design of novel proteins and protein ligands, including pharmaceutical agents. This research project will use multidimensional NMR spectroscopy to address these fundamental issues. One long-term goal is to define the molecular determinants of stability and catalytic activity of the enzyme ribonuclease HI (RNase H) by comparing the structural, dynamical and enzymatic properties of homologous proteins derived from Escherichia coli and the extremely thermophilic bacterium Thermus thermophilus. The enzyme hydrolyzes the RNA strand of DNA/RNA hybrid molecules involved in DNA replication, viral reverse transcription, and antisense technology. RNase H is distributed widely in prokaryotes and eukaryotes, and HIV retroviral reverse transcriptase contains a C-terminal RNase H domain. The specific aims for this project are to determine the molecular determinants of the difference in catalytic activity of the two homologous enzymes at moderate temperatures and to determine how necessary conformational rigidity is maintained by the thermophilic protein at elevated temperatures. Another long-term goal is to define the molecular determinants of ligand binding, including aspects of specificity, in DNA recognition by the yeast protein GCN4. Motifs that recognize specific DNA sequences are ubiquitous components of proteins that regulate gene expression. GCN4 is the prototypical member of the bZip family of transcription activators and represents an example of induced fit molecular recognition through a disorder-order transition associated with DNA binding. The specific aim for this project is to evaluate the role of transient local structures in the molecular recognition mechanism. These objectives are supported by a specific aim to develop improved approaches for characterizing protein dynamics by NMR spectroscopy and computer simulation. This research will explicate molecular aspects of catalysis and recognition in these two paradigmatic systems that are critical for understanding normal and abnormal biological functions. PUBLIC HEALTH RELEVANCE: Processing of DNA and RNA molecules by proteins is fundamental to human health, including cell division and homeostasis, and disease, including cancer and viral infection. Proteins of the ribonuclease H family of enzymes and the bZip family of transcription factors are the subjects of the proposal and are paradigms for understanding aspects of catalysis of DNA/RNA hybrid molecules in replication and reverse transcription and of molecular recognition of DNA in gene regulation.

Public health relevance
Processing of DNA and RNA molecules by proteins is fundamental to human health, including cell division and homeostasis, and disease, including cancer and viral infection. Proteins of the ribonuclease H family of enzymes and the bZip family of transcription factors are the subjects of the proposal and are paradigms for understanding aspects of catalysis of DNA/RNA hybrid molecules in replication and reverse transcription and of molecular recognition of DNA in gene regulation.